Applied Research Section

ABSTRACT: Applied Research Section
Development of Mouse Oocyte Vitrification Methodology in a Closed System
For the Mutant Mouse Resource and Research Center (MMRRC) Consortium, highly effective and efficient
cryopreservation methods using slow freezing have been established to preserve genetically modified mouse
lines as frozen sperm and embryos that can then be recovered using in vitro fertilization (IVF) and/or surgical
embryo transfer (ET) to live mice for sharing and distribution. On the other hand, not all mutant mouse lines
can be safely and securely preserved by cryopreservation of embryos and/or sperm, such as those exhibiting
male infertility or poor embryo development. Even fertile and viable mouse lines are not always amenable to
cryopreservation and/or cryorecovery of sperm and embryos, often due to the vagaries of genetic background,
fecundity, in vitro manipulation, embryo culture factors, etc. In these cases, the ability to preserve mouse
oocytes could provide a suitable alternative and added flexibility to ensure the safe and secure preservation of
mutant mouse lines. A reliable and reproducible method for oocyte preservation would complement, and in
some case, replace existing procedures used on sperm and embryos. Unfortunately, oocytes are notably
vulnerable to slow freezing, which causes intracellular ice formation, premature hardening of the zona pellucida
(ZP), and significantly reduced oocyte fertility by IVF. On the other hand, rapid freezing via vitrification
overcomes the biophysical deficiencies of slow freezing and can increase the survivability of oocytes. We have
identified three components of current protocols that can be readily modified to significantly improve the
success of vitrification of mouse oocytes: 1) inhibition of ovastacin protease activity, 2) reduction in reactive
oxygen species (ROS), and 3) chelation of free calcium and zinc ions. In addition, a closed system will be
needed to avoid the risk of microorganism contamination and pathogen cross contamination of oocytes during
vitrification. Therefore, we hypothesize that inhibition of ovastacin protease activity, reduction in reactive
oxygen species, and chelation of free calcium and zinc under closed conditions will preserve the integrity of the
zona pellucida and dramatically improve the viability and fertility of vitrified mouse oocytes. This proposal will
have 3 Specific Aims to develop this new vitrification and recovery protocol on the C57BL/6N genetic
background, which is the same as that for many mutant mouse lines distributed by the MMRRC, including from
the KOMP2 mutant mouse collection. After verifying the new protocol on wildtype mice, we will validate its
applicability to reliably preserving several MMRRC mutant mouse lines on various genetic backgrounds in
which traditional sperm and/or embryo cryopreservation methods are inappropriate or ineffective. Ultimately,
funding of this project will enable a systematic approach for optimizing vitrification in order to establish a
dependable, reproducible, and effective vitrification protocol that will be published and shared with all 4
Centers in the MMRRC consortium and can be broadly adopted across the biomedical research community,
including and especially for the preservation of mutant mouse lines by the MMRRC. Doing so will dramatically
improve the protection of valuable genetic material, enhance repository operations, reduce overall costs, and
contribute to scientific rigor and reproducibility.

Public health relevance
PROJECT NARRATIVE: Applied Research Section This proposal from the Mutant Mouse Resource and Research Center at UC Davis (MMRRC-UC Davis) seeks to develop new technological approaches for the efficient preservation of mouse oocytes by vitrification. We hypothesize that inhibition of ovastacin protease activity, reduction in reactive oxygen species, and chelation of free calcium and zinc under closed conditions will preserve the integrity of the zona pellucida and dramatically improve the viability and fertility of vitrified mouse oocytes. Our approach will be to 1) establish a closed vitrification method using Ca2+-free freezing medium supplemented with fetal bovine serum (FBS) or Fetuin‐B, antioxidants, and chelating agents, 2) assess fertility of vitrified oocytes by in vitro fertilization and embryo culture in vitro, and 3) determine viability of fertilized vitrified oocytes by embryo transfer and production of liveborn offspring. We will share the optimized protocol directly through the Cryopreservation Subcommittee with other members of the MMRRC consortium and indirectly through peer-reviewed publication with the biomedical research community. The outcome of this research will be a new, improved, and reliable method for high fidelity vitrification of mouse oocytes to increase the preservation, security, protection, and reproducibility of mutant mouse lines for biomedical research, especially those for which traditional sperm and embryo cryopreservations are inappropriate, ineffective, or unreliable.